Tissue engineered Nigrostriatal Pathway as a testbed for evaluating axonal pathophysiology in Parkinson's disease.

PROJECT SUMARY
Parkinson’s Disease (PD) is a progressive neurodegenerative disease with 50,000-60,000 diagnoses annually
and over 1 million Americans afflicted in total. PD-associated motor symptoms arise from the selective loss of
dopaminergic neurons in the substantia nigra pars compacta (SNpc). Because SNpc neurons send long-
projecting axons to the striatum, this stereotypical neurodegeneration robs the striatum of crucial dopaminergic
inputs and thereby renders an important motor feedback pathway ineffective. Alpha synuclein protein is known
as the pathological hallmark of PD pathology. The function of alpha synuclein in the healthy brain is not
completely understood, however it is transported down axons in abundance, is highly enriched in presynaptic
terminals, and is believed to be responsible for the transmission and progression of PD pathology across
different regions of the nervous system. Although researchers have learned a great deal about PD
pathophysiology through cellular and animal models, the findings have had limited translational impact due to
challenges in recapitulating the most disease-relevant attributes of human brain structure and function. In
particular, there are limitations of current in vitro and in vivo models to recapitulate essential features of human
disease related to axon pathophysiology and synuclein transmission. For instance, a key feature related to
early SNpc vulnerability is that each dopaminergic neuron features a long-projecting axon with complex
arborization that can total 15 feet in length within the striatum, incurring unique transport and metabolic needs
of these neurons. This feature of long axonal projections from human derived dopaminergic neurons – the
human source ensuring a genetic endowment capable of developing and responding to synucleinopathy –
projecting to a striatal neuronal source has been absent in preclinical models of PD thereby underrepresenting
the role of axonopathy and metabolic susceptibility in PD pathogenesis. To address this need, we have
developed the first tissue engineered nigrostriatal pathway (TE-NSP) recapitulating key elements of the native
pathway: discrete human stem cell derived, phenotypically-controlled neuronal populations connected by long-
projecting axonal tracts. This project will validate TE-NSPs as the first PD model featuring anatomically
inspired microtissue, and then apply this novel platform for the study of PD axonopathy, mechanisms of
synuclein transmission, and pharmacological interventions to block axon-mediated spread of pathological
alpha-synuclein across discrete brain structures. We will first demonstrate that TE-NSPs appropriately
recapitulate the relevant systems-level architecture by identifying all source and target cell types,
characterizing synaptic formation with presynaptic and postsynaptic markers, and demonstrating input-output
based on evoked dopamine release (AIM 1). We will then model PD via the addition of exogenous alpha
synuclein fibrils and characterize acute axonal pathophysiological changes to axon length and density, tyrosine
hydroxylase expression, alpha synuclein transfer from dopaminergic to medium spiny neurons, and affects on
dopamine release (AIM 2). Finally, we will utilize TE-NSPs as a testbed for evaluating therapeutic strategies
aimed at inhibiting alpha synuclein spread through MTOR inhibition (AIM 3). We have assembled a multi-
disciplinary team of researchers consisting of stem cell specialists, neurobiologists, tissue engineers, and
clinicians to validate and apply this novel in vitro platform. Successful demonstration of this platform will
significantly advance a translational approach to ultimately build personalized TE-NSPs using dopaminergic
neurons derived from PD patients to evaluate the neuroprotective efficacy of pharmacological therapies
targeted at preventing alpha synuclein transmission to delay and/or prevent axonal/neuronal degeneration in a
patient-specific manner.

Public health relevance
PROJECT NARRATIVE Parkinson's disease (PD) is a life-destructive neurodegenerative disease that affects over 1 million Americans with no available treatment to slow disease progression. Although researchers have learned a great deal about PD pathophysiology through cellular and animal models, the findings have had limited translational impact due to challenges in recapitulating the most disease-relevant attributes of human brain structure and function. The field is in need of a high-throughput PD testbed that features a three-dimensional structure mimicking key features of PD vulnerability and pathology, including human neural cell populations organized based on systems-level architecture that are – most importantly – spanned by bundled long-projecting axon tracts. As such, this project will validate the first PD model featuring anatomically inspired microtissue, and then apply this novel platform for the mechanistic study of PD axonopathy, pathophysiology, and pharmacological interventions to block axon-mediated spread of pathological alpha-synuclein across discrete brain structures. !